Renal Oxygenation in the Pathophysiology of Kidney Disease

DESCRIPTION (provided by applicant): In chronic kidney disease (CKD), intrarenal hypoxia has been identified as a major contributor to disease progression. Hence, it is imperative to understand the pathways that regulate kidney oxygenation in health and disease. At the earliest stages, a functional oxygen supply-demand mismatch creates a hypoxic environment. High nephron oxygen consumption without an increase in oxygen supply is the earliest pathophysiological change that leads to oxygen supply-demand mismatch. Lowering nephron oxygen consumption improves kidney function and morphology. This proposal is aimed at investigating the regulators of oxygen consumption at the earliest stages in subtotal nephrectomy, a rodent model of CKD. The strategy and overall objective is to investigate key pathophysiological events and their regulation early in the course of disease before irreversible structural changes set in and to identify novel therapeutic targets which can prevent or slow the progression of CKD. The majority of the energy in the kidney is provided by oxidative phosphorylation by the mitochondria. Preliminary data demonstrates several alterations in mitochondrial function and morphology in early subtotal nephrectomy indicating mitochondrial stress. Hypoxia inducible factor (HIF) transcription complex is a primary oxygen sensor/regulator of oxygen homeostasis and induces several target genes that impact oxygen delivery and consumption. It also has several beneficial effects on mitochondrial function. AMP-activated protein kinase (AMPK) is another important energy sensor that regulates cellular metabolic adaptations under ATP-deprived conditions and is increasingly being identified as a major player in renal pathophysiology. HIF and AMPK are also emerging as regulators of sodium transport, which is a primary driver of nephron oxygen consumption. Based on the preliminary data, the overall hypothesis is that hypoxia in early subtotal kidney, due to increased nephron oxygen consumption, leads to mitochondrial dysfunction and ROS generation, resulting in tissue injury and renal dysfunction. This is perpetuated by abnormal cellular stress adaptation due to suppressed AMPK activation. HIF-1 induction improves renal oxygenation by lowering oxygen consumption and increasing oxygen supply via effects on renal hemodynamics, salt transport and cellular effects including improvements in mitochondrial morphology and function and restoration of AMPK activation. The specific aims are to determine the subcellular, cellular and hemodynamic mechanisms whereby HIF-1 activation improves renal oxygenation in early CKD and to determine the significance of the AMPK pathway in renal function and oxygenation by examining its role in tubular transport and metabolism in early CKD. These investigations will not only provide important and novel insights into the early mechanisms of disease progression and identify treatment strategies that can be employed early to prevent the usual course of disease progression, but the broad-based approach will also serve as a spring-board for future proposals on specific mechanistic pathways underlying the coordinated actions of HIF and AMPK in the regulation of energy metabolism and transport at a cellular and subcellular level. The understanding obtained from these investigations will be valuable beyond the model studied given the universal implications of mitochondrial dysfunction in various pathophysiological conditions and the nearly ubiquitous cellular expression of HIF and AMPK in several organs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Chronic kidney disease (CKD) is an important healthcare problem with significant morbidity, mortality and devastating progression to End-Stage Renal Disease. Nearly 20 million adults in the United States suffer from CKD. The veteran population is particularly affected by this condition due to the high incidence of precursors such as diabetes, hypertension and heart disease. Existing therapies targeting known mechanisms of disease progression have been inadequate in improving the outcomes. The factors involved in early stages are poorly understood and, hence, and not amenable to specific treatment. Most cells in the body require an interrupted supply of oxygen for optimal function. Low oxygen environment has recently been proposed as a major pathway for disease progression in CKD. The major goal of this research proposal is to identify and investigate new pathways that regulate kidney oxygenation early in the course, before there is permanent structural damage, which will allow the development of new treatments to halt or slow the worsening of kidney disease.